Unraveling the Regulation of Transcription and Activity of Calcium Transporter SLC24A4 in Enamel Formation

Project Summary/Abstract
The exceptional strength of enamel can be attributed to its high mineral content within the matured matrix.
This biomineralization process relies heavily on maturation ameloblasts (MABs), responsible for transporting
approximately 86% of the required minerals. Among the key players in this intricate process is the K+-
dependent Ca2+/Na+-exchanger SLC24A4. Disruptions of SLC24A4 contribute to the development of an
enamel disorder called amelogenesis imperfecta. SLC24A4 is highly upregulated in those post-secretory
stages of ameloblasts, where it shuttles between the apical plasma membrane (PM) of the ruffle-ended and
the cytosol of the smooth-ended MAB subpopulations. The mechanisms governing SLC24A4’s temporal and
spatial expression in MABs remain largely unexplored. During development, secretory ameloblasts (SABs)
are succeeded by the transition stage of ameloblasts (TABs). TABs play a crucial role in modifying the protein
composition and mechanical stress within the underlying enamel matrix by introducing the potent proteinase
KLK4. Our preliminary data indicated that factors present in the transition stage of enamel, including
amelogenin hydrolysis peptides (Amelx20, C-domain, and C-P1), along with gradually intensified mechanical
stiffness, enhance the transcription of Slc24a4. Additional data indicated a correlation between the
transcription of Slc24a4 and heightened levels of H3K4 methylation. Simultaneously, we discovered that
exposure to BSA-saturated palmitic acid (PA) elevated the levels of protein palmitoylation and enriched
SLC24A4 along the PM of ameloblast lineage cells (ALCs). Furthermore, our findings revealed a significant
concentration of palmitoyltransferase ZDHHC21 within PM of the ruffle-ended MABs, implying a potential role
of protein palmitoylation in the cellular trafficking of SLC24A4. We hypothesize that the combined influence
of developmental cues and protein palmitoylation regulates the calcium transport capacity of SLC24A4 at
both the transcriptional and activity levels. To investigate this hypothesis, we have formulated two specific
aims. Specific aim 1: To determine the molecular mechanisms underlying the upregulation of SLC24A4
transcription in MABs. To assess the impact of development cues, we will conduct a comparative analysis of
H3K4me3 marks in ALCs treated with and without these cues using ChIP-seq. To validate the intensity of
H3K4me3 marks in the regulatory region of the SLC24A4 gene within rare cell populations of wt mouse SABs
and MABs, we will employ the recently developed CUT&Run-seq analysis. Specific aim 2: To define the
significance of protein palmitoylation in governing the activity of SLC24A4. We propose to quantitate the
protein palmitoylation levels of SLC24A-transduced ALCs treated with or without BSA-PA using click
chemistry and proximity ligation assay. Next, we aim to determine the palmitoylation sites of SLC24A4 using
immunoprecipitation and mass spectrometry. Understanding the factors and mechanisms that regulate
SLC24A4 transcription and activity is important for both enamel biology and regenerating ameloblast/enamel.

Public health relevance
Project Narrative Enamel, the hardest tissue found in all vertebrates, is composed of 96% minerals within its erupted matrix. Of these minerals, over 86% are transported by maturation ameloblasts. This project aims to explore the regulatory mechanisms governing the calcium transport facilitated by the maturation stage of ameloblast SLC24A4 at both the transcriptional and activity levels.